EFFECT OF AMINO ACID LOAD ON RENAL FUNCTION AND NUTRITIONAL STATUS

The objectives of this study are to (1) determine the effect of the infusion of two different levels of amino acids (0.5 gms/kg/day vs 1.5 gms/kg/day) on the rate of recovery of renal function in patients with non-oliguric acute renal failure and (2) to determine is 0.5 gms/kg/day of amino acid is sufficient to maintain appropriate nutritional status in these patients.